IGF::OT::IGF-Base Award and Task Orders 1 and 2. Period of Performance 09/15/2016-02/14/2017. Synthesis and Distribution of Opioid and Related Peptides.

Synthesis and purification of opioid and related peptides (Radiolabeled and/or unlabeled) at a purity of 99% minimum.